Balanced Energy Protein Supplement in Early Lactation on Infant Growth in Southern Nepal

ABSTRACT
Undernourished women in low-and-middle income countries (LMICs) experience greater fetal growth restriction
in pregnancy and poorer birth outcomes, including preterm birth and small-for-gestational age (SGA). Infants
born preterm and/or SGA are more vulnerable to stunting and inadequate neurocognitive development, with
lasting effects through adulthood. Nutritional interventions targeted in pregnancy and lactation have the
potential to break the intergenerational cycle of malnutrition. Recently, an expert consensus developed
specifications for a fortified BEP “ready-to-use” food supplement for pregnant and lactating women in LMICs,
which requires testing in undernourished settings for efficacy in improving birth and growth outcomes.
Currently, there is no recommendation for supplementation for women who are breastfeeding, despite high
rates of growth faltering in early life in LMICs, where maternal undernutrition is high and exclusive
breastfeeding is recommended. Our research aims to 1) Evaluate the effect of daily BEP++ in pregnancy
and/or lactation on infant growth outcomes in the first 6 months of life; 2) Evaluate the effect of daily BEP++ in
pregnancy and/or lactation on maternal nutritional status and explore potential mediation pathways on infant
growth outcomes; and 3) In a biospecimen sub-study, explore relationships between maternal and infant
nutrient status, inflammation, human milk composition, and gut microbiome by supplementation in pregnancy
and/or lactation vs. not. We propose a community-based, randomized controlled trial of daily BEP++
supplementation during lactation in rural Nepal (proposed addition). Our study population has high rates of
maternal undernutrition, adverse birth outcomes, and poor infant growth, and is representative of rural settings
in South Asia. To conduct this trial, we will leverage the infrastructure of our community-based field site and a
randomized trial of a BEP++ supplement in pregnant women scheduled to begin in 2022 (parent trial). The
parent trial will recruit pregnant women in pregnancy, randomize them to supplement in pregnancy or no
supplement, and follow-up until birth to assess SGA incidence. We propose to 1) add a postpartum
supplementation trial following supplementation in pregnancy, using a 2x2 factorial design, to evaluate the
BEP++ supplement during lactation and measure infant growth outcomes at 6 months of life, 2) double the
overall sample size of pregnant women enrolled to allow for detection of meaningful differences between
postpartum supplementation, and 3) nest a biospecimen sub-study within the trial to explore aims on the
causal relationships between maternal and infant nutritional status and infant growth. A sample of 2,000
pregnant women will yield 1,600 live births and 1,440 infants followed until 6 months (accounting for pregnancy
loss and loss to follow-up). This will allow us to detect a difference for our primary outcome, mean length-for-
age Z score at 6 months, between supplement in lactation vs. no supplement, of 0.16 Z scores.

Public health relevance
PROJECT NARRATIVE Infant nutritional status at birth and catch-up growth in the first 6-months of life, especially in preterm and small-for-gestational age infants, have been shown to be critical determinants of childhood growth outcomes and associated with risk for mortality, morbidity, and developmental outcomes. Studies of nutritional interventions to improve infant growth among these vulnerable infants are needed in rural, low- resource areas in South Asia, where maternal undernutrition, adverse pregnancy outcomes, and poor growth outcomes are common. If efficacious, a balanced energy protein nutritional supplement with multiple micronutrients and calcium, provided to mothers during pregnancy and lactation, could improve maternal nutrition and infant growth in their first 6 months of life and beyond.